Natural Killer Cell Tolerance to Self

Abstract
Natural killer (NK) cell tolerance to self is incompletely understood despite wide-spread
acceptance of the now familiar “missing-self” hypothesis. Serving as a guiding principle for
several decades, it proposed that NK cells survey tissues for ubiquitously expressed major
histocompatibility complex class I (MHCI) molecules as self. Normal levels of MHCI do not
allow NK cell attack but if MHCI is down-regulated in a pathologic event, NK cells attack. The
applicant and his laboratory discovered the Ly49 family of receptors specific for target cell
MHCI molecules that inhibit NK cell activation receptor function, providing a basis for
understanding the missing-self hypothesis. However, some predictions of the missing-self
hypothesis were not observed, such as hyper-reactive NK cells in MHCI-deficient hosts, rather
hypo-responsive NK cells were found. This can now be explained by other findings from the
applicant's laboratory that the inhibitory Ly49 receptors have a second function to license or
educate NK cells to self-MHCI, such that licensed NK cells have functionally competent
activation receptors. Meanwhile, other issues. For example, in prior studies, the applicant's lab
showed that different MHCI alleles appear to have graduated effects on Ly49 functions,
suggesting signaling strength accounts for these functions, possibly due to Ly49 affinities for
self-MHCI, in part related to the rheostat model for receptor function that has not been well
studied. Moreover, MHCI affects the repertoire of Ly49s that are expressed in a variegated
manner with more than one Ly49 per NK cell. Data from the applicant's laboratory suggest that
signaling by a self-MHCI-specific Ly49 influences expression of another Ly49 that is self-MHCI-
specific, potentially providing an explanation for how MHCI alleles affect the Ly49 repertoire.
Finally, it is not known how the Ly49s confer licensing, such as the possibility that the inhibitory
receptors may directly signal the licensing phenotype. Herein the applicant proposes to study
NK cell tolerance utilizing novel mice recently generated in his laboratory, including knockout
mice lacking all Ly49 expression on conventional NK cells and knockin mice with essentially
monoclonal expression of a single Ly49 on all NK cells. Therefore, the Specific Aims of this
proposal are to study: 1) Ly49 affinity for self-MHCI in licensing, effector inhibition and
missing-self; 2) Establishment of the Ly49 repertoire; and 3) Inhibitory Ly49 signaling. Thus,
these studies will markedly enhance our understanding of NK cell tolerance.

Public health relevance
Project Narrative This project deals with natural killer (NK) cells which are immune cells that can control infections and tumors. NK cells have potent mechanisms to attack and destroy abnormal cells and promote inflammation, processes that must be controlled, termed tolerance. Here the Yokoyama laboratory presents preliminary evidence using novel experimental tools that will be used in the current proposal to study how NK cells are prevented from inadvertent attack.